Evaluation of a Sexual Violence and Intimate Partner Violence Primary Prevention Program Implemented in Drinking Establishments in Sacramento County, California

PROJECT SUMMARY
The overarching goal of this project is to evaluate the effectiveness of Safe Night Out (SNO), a community-level
primary prevention program offered in drinking establishments in Sacramento County, California. Developed and
implemented in 2019 by WEAVE, Inc., Sacramento County’s primary domestic violence (DV) provider, SNO aims
to train nightlife staff on how to recognize warning signs of sexual violence (SV) and intimate partner violence
(IPV), and how to respond through active bystander skills to keep patrons safe. SNO has been tailored for
drinking establishments in predominantly LGBTQ+ neighborhoods given the disproportionate rates of SV and
IPV among sexual and gender minorities. SNO, a single session education and bystander skills training, is to
our knowledge, the only program implemented in LGBTQ+ drinking establishments. Guided by Social Cognitive
Theory, Social Norms Theory, and the Bystander Education Model, and in collaboration with our Research
Advisory Board, our community-academic team will conduct a quasi-experimental mixed methods evaluation
study using a comparative time-interrupted series design to Aim 1: Determine the effectiveness of SNO on
increasing bystander intervention and reducing SV and IPV at the individual-level (e.g., patrons, staff) and
population-level (e.g., census block). Individual-level primary outcomes among patrons include past 6-month SV
and past 6-month IPV victimization and perpetration; secondary outcomes among staff include past 6-month
increase in bystander intervention and safety checks in drinking establishments. We will also determine the
effectiveness of SNO on 2-year average rates of rape, domestic violence assault and domestic violence police
calls. Aim 2: Examine moderators (e.g., age, sex, history of SV/IPV) and mediators (e.g., self-efficacy, social
norms) impacting the effectiveness of SNO on reducing SV and IPV and increasing bystander intervention
among patrons and staff, respectively. Aim 3: Assess implementation processes based on the RE-AIM
framework, on SNO reach, integration, fidelity, and engagement as well as costs associated with SNO program
implementation. We will enroll 25 drinking establishments in the queue at WEAVE to receive SNO training and
identify 25 drinking establishments who will not receive the SNO training during the study period. This will allow
for comparison between the two groups based on individual-level and staff-level outcomes, before (3 months
prior) and after SNO program training (6, 12, and 18-month follow-up) using quantitative survey data (n=500
patrons, 10 per establishment and n=75 staff, 3 per establishment). We will also examine the annual rates of
reported sexual assault and domestic violence calls before implementation of SNO training that was tailored to
LGBTQ+ communities (2019-2021) and after SNO training implementation (2022-2025). Finally, we will use
quantitative survey and qualitative data (n=9 patron focus groups [FG], and n=9 staff FG, 5 per FG) to evaluate
implementation outcomes and conduct cost analysis. If effective, SNO will serve as an evidence-based program
that can be scaled up in other LGBTQ+ drinking establishments in the U.S.

Public health relevance
PROJECT NARRATIVE The goal of our mixed methods evaluation study is to determine the impact of Safe Night Out – an integrated education and skills training in active bystander intervention for staff at drinking establishments developed by WEAVE (a domestic violence agency) – on prevention of sexual violence and intimate partner violence, with a focus on sexual and gender minorities. If effective, Safe Night Out can serve as an evidence-based model for other geographic areas with high prevalence of sexual and gender minority individuals.